TRIAL OF LINGUAL LIPASE TO CORRECT MALABSORPTION IN CYSTIC FIBROSIS

Complete correction of malabsorption in patients with CF is frequently not possible because lipase is acid sensitive. This project will test a preparation of lingual lipase which is acid resistant in these patients.